Biostatistics Core

Core B (BIOSTATISTICS and BIOINFORMATICS CORE) – ABSTRACT
The Biostatistics and Bioinformatics Core (Core B) provides statistical and bioinformatics collaboration and data
management support for each of the three main projects, pilot projects, and the other cores in the Mayo Clinic
Hepatobiliary Cancers (HBC) SPORE. Core B provides the HBC SPORE investigators with integrated access to
the extensive infrastructure of the Mayo Clinic Comprehensive Cancer Center Biostatistics and Bioinformatics
Core, methodological expertise in state-of-the-art human tumors and model systems (e.g., cell lines, patient-
derived xenografts), multi-omics data analysis, clinical trial designs, cancer population studies, and cancer
predictive modeling. Under the current HBC SPORE, Core B collaborative efforts for HBC SPORE projects have
included the development of statistical design and analysis plans, quality control, database development and
management, data pre-processing for bioinformatics workflows, computational genomics analyses, data
analysis, integration, and interpretation, manuscript preparation, data archiving, and execution of data sharing
plans. Through Core B, HBC SPORE investigators will continue to have direct access to a fully collaborative
team of statistical/bioinformatics collaborators with content knowledge of HBCs. The resources of Core B ensure
the development of study designs that address the questions posed using statistical and bioinformatics analysis
techniques that are appropriate for the complex data generated in these diverse projects. In summary, Core B
will continue to ensure that all analytic activities in the HBC SPORE are carried out in an efficient, effective, and
rigorous manner.

Public health relevance
CORE B (BIOSTATISTICS AND BIOINFORMATICS) – PROJECT NARRATIVE The Biostatistics and Bioinformatics Core collaborates with HBC SPORE investigators in designing studies and clinical trials, determining optimal data collection methods, performing data management and quality control, and in analyzing and interpreting study results. The Biostatistics and Bioinformatics Core interacts with the Biospecimen and Pathology Core, ensuring optimal use of resources and outstanding quality research with the utmost reliability.